DEVELOPMENTAL RESEARCH PROGRAM--BREAST CANCER

The SPORE's Developmental Research Program consists of two components: A) the continued funding and tracking of 1-year pilot projects, and B) the funding of two new longer-term developmental projects. To date, this SPORE program has funded 15 pilot projects (with 3 renewals for an additional year) from a pool of 25 applicants; the pilot project program and these 15 projects are reviewed in the following section. In years 04-08 we intend to support an additional 5 -10 pilot projects per year. In addition, as proposed in the PI's Introduction to this SPORE renewal application, the SPORE's Developmental Research Program will also support two new developmental projects: i) DP#1, "Ligand mediated targeting of retrovirus to breast cancer," Y.W. Kan, PI; and ii) DP#2, "Genomic instability in carcinogenesis of the breast," T.D. Tisty, PI. These unique and highly promising developmental projects are being given special emphasis since they will bring important new dimensions to our overall SPORE. Each of these two developmental project proposals included in the following section is presented independently and in standard NIH project application format.